PORPHYRIN AND CORRINOID BIOSYNTHESIS

Using a combination of organic chemistry, molecular biology, enzymology, and NMR spectroscopy the details of the biosynthesis of uroporphyrinogen III (theprecursor of heme and chlorophyll) and its subsequent transformation to vitamin B12,the anti-perinicious anemia factor, will be elucidated. Knowledge of the pathway including control mechanisms and genetic mapping will define intermediates important in diseases such as B12 deficiency and acute intermittent porphyria. All of the biosynthetic enzymes necessary for the formation of cobyrinic acid, the simplest B12 analog, will be overexpressed using the sequenced cbi genes of Salmonella typhimurium and the cob genes of Pseudomonas denitrificans and their mechanisms studied by NMR spectroscopy via13C- labeling. Finally, the multi-enzyme synthesis of advanced intermediates and of B12 itself will be addressed.